Perinatal exposures, epigenetics, child obesity & sexual maturation

Description (provided by applicant): The overall goal of the Administrative Core is to provide oversight, coordination, and integration of Center activities. The Specific Aims are to: 1) Coordinate and integrate the scientific aims of the Projects and Cores, track their progress and outputs, and make adjustments as needed as the activities of the Center progress; 2) Conduct resource management planning to assure that Project and Core needs are met; 3) Organize meetings of the Project and Core leaders, facilitate interactions and disseminate recommendations by the External Advisory Committee; 4) Track the progress and success of Career Development and Community Engagement Plans; and 5) Prepare Center-wide reports, and communicate with NIEHS, EPA, and other participating research, training, and community units or organizations. The Core will operate through an Executive Committee composed of Administrative Core personnel (Core Leader/PI; Core Co-Leader and Pediatric Health Specialist) and Leaders of each of the Projects and Cores. The Administrative Core will ensure coordination of Center activities and plan and assess resource management within and across Cores and Projects. At regularly scheduled meetings, Executive Committee members will track accomplishment of research goals according to the proposed timeline, and review coordination and resource needs across the Projects and Cores, to identify the most efficient use of the infrastructure and communications to resolve needs as they arise. Implementation of the Center's Program Integration plan is a central responsibility of the Administrative Core to capitalize on the synergy potential between Projects, the Environmental Biostatistics Core, and with other Centers and investigators throughout the Michigan Research Corridor (made up of UM, Michigan State, and Wayne State Universities). The Core will interact with the External Advisory Board and other Stakeholders to optimize research and translation outputs. Finally, the Administrative Core will implement a Career Development and Training plan and ensure that these activities are fully integrated with the Center's research projects and Environmental Biostatistics Core Public Health Relevance: The goal of the Administrative Core is to oversee, coordinate and integrate all Center activities in order to ensure realization of specific aims for each of the Research/Pilot Projects and the Environmental Biostatistics Core, integration of Career Development & training with research and active engagement with External and Stakeholder Advisory Groups to promote achievement and translation of Center research.

Public health relevance
Our Center's work promises to improve our understanding of a) the contribution of environmental exposures (lead, bisphenol A, and phthalates) toward the etiology of child obesity and sexual maturation; and (b) the role of epigenetic reprogramming in such effects. These insights, in turn, wili create new opportunities for children's risk assessment and disease prevention, diagnosis, and treatment.